Role of VGLL1 in human placental development and trophoblast specification

Project Summary/Abstract
Many placenta-associated pregnancy complications, including pre-eclampsia (PE) and intrauterine
growth restriction (IUGR), originate in the early stages of placental development, during the
establishment of trophoblast cells, the functional building blocks of the placenta. Due to the
inaccessibility of this early stage of human development, most of what we know about this process
comes from other species, in particular, from mice. Trophoblast specification in pre-implantation
mouse embryos is dependent upon the Tead4/Yap1 complex initiating a trophoblast-specific
transcriptional program. However, an increasing body of evidence, from our lab and others’, shows
significant species-specific differences in trophoblast lineage specification between mouse and human.
In a recent comparative placentation study, we identified the transcriptional co-factor vestigial-like
family member-1 (VGLL1) as a human-specific marker of early gestation cytotrophoblast (CTB), the
stem cell compartment of the human placenta. VGLL1 co-localizes with TEAD4 and TP63 in early
gestation CTB. Furthermore, expression of VGLL1 is induced very early during trophoblast
differentiation of human pluripotent stem cells (hPSCs) following BMP4 treatment, before induction of
TP63. Little is known about VGLL1 function, but interestingly, VGLL1 has been shown to bind TEAD4,
in a manner similar to the Tead4/Yap1 interaction, which is required for trophoblast lineage
specification in mice. This project aims to elucidate the role of VGLL1 as a human-specific
regulator of trophoblast lineage specification. We will manipulate VGLL1 expression using
CRISPR/Cas9 technology in both novel human trophoblast stem cell lines and an in vitro hPSC-based
model of human trophoblast lineage specification. We will assess the effects of such manipulation on
trophoblast maintenance, differentiation and function, as well as genome-wide changes in RNA
expression. We will confirm the interaction between VGLL1 and TEAD4 in both systems and identify
direct downstream targets of the VGLL1-TEAD4 complex using ChIP-seq. We hypothesize that VGLL1
is a key player involved in trophoblast lineage specification in early human development, acting in
complex with TEAD4, to induce a TP63-based transcriptional program to establish and maintain
trophoblast stem cells in the human placenta.

Public health relevance
Project Narrative The pathophysiology of many placenta-associated pregnancy complications, including pre-eclampsia (PE) and intrauterine growth restriction (IUGR), is poorly understood, mainly because the human placenta remains an understudied organ. This project will elucidate the specific transcriptional program that establishes and maintains the trophoblast stem compartment in human placentas and driven by the transcription factor VGLL1. Because VGLL1 acts specifically in the human placenta, we will gain insight into the molecular mechanisms involved in early development of normal placenta, which has been identified as a priority area of the Pregnancy and Perinatology Branch of the NICHD.